TOTAL HIP ARTHROPLASTY--EVALUATION OF NEW PROSTHESES

Post-surgery evaluation of joint flexibility, patient pain indices, and prosthetic integrity. This project used Informatics Core for analysis of data.